Dissecting the role of ZCWPW1 in oocyte quality, fertility and ovarian physiology.

PROJECT SUMMARY: Gametogenesis relies on a specialized cell division called meiosis, where homologous
chromosomes pair together, exchange genetic information through induced DNA double-strand breaks (DSBs)
and separate into haploid daughter cells. The sites of homologous recombination (HR) events in mammals,
called crossovers (COs), are determined by PRDM9, an H3K4/K36 methyltransferase. Recent evidence
highlights the significance of symmetric PRDM9-dependent modifications—chromatin modifications on both
homologs at the same genomic loci—for early inter-chromosomal pairing events and subsequent CO formation.
However, it remains unknown how the symmetric PRDM9-dependent modifications directly influence meiotic
homolog associations and downstream DSB repair. Our team and others have identified a dual H3K4/K36me3
reader, ZCWPW1, that may coordinate PRDM9-dependent modifications and downstream recombination.
Consistent with this model, Zcwpw1-/- males are sterile, with their spermatocytes displaying a failure to repair
DSBs and display chromosomal aberrations, including elevated rates of heterologous association. In contrast,
Zcwpw1-/- females, while initially fertile, become sterile at 6-8 months due to premature ovarian failure. Here we
will examine the role of ZCWPW1 in female meiosis. This milder phenotype in females allows us to define
ZCWPW1's role in homolog pairing and recombination and its contribution to meiotic prophase progression and
oocyte elimination or survival. To dissect the role of ZCWPW1 in homolog pairing and DSB repair, we propose a
comprehensive and integrative analysis of ZCWPW1 function using a series of genetic models and molecular
techniques. Overall, these studies will provide fundamental insights into female meiotic chromosome dynamics
and a mechanistic understanding of the role of ZCWPW1 in oocyte quality control and ovarian reserve
establishment and maintenance.

Public health relevance
PROJECT NARRATIVE: This proposal will detail my progress and future plans to examine the function of meiotic histone reader ZCWPW1 in ovarian reserve formation, genomic fidelity, and oocyte quality. Through this work, I hope to identify the keystone factors that regulate oocyte quality and characterize their impact on ovarian physiology and fertility. This proposal has applications to our understanding of human infertility, early embryonic miscarriages, and primary ovarian insufficiency.